Understanding the Pathogenic Mechanisms of Rett Syndrome

Title
Understanding the pathogenic mechanisms of Rett syndrome
Abstract
Rett Syndrome (RTT) is an X-linked neurodevelopmental disorder caused by mutations in methyl-CpG binding
protein 2 (MECP2) gene. It occurs primarily in heterozygous females and represents one of the leading causes
of intellectual disability in women. Despite its seemingly simple genetic root and the significant research
progress thus far, the molecular mechanisms underlying RTT pathogenesis, such as the delayed onset and
progressive clinical course, remain poorly understood. This is partially because mechanistic studies in
heterozygous females are confounded by random X-chromosome inactivation (XCI) and the resulting mosaic
expression of X-linked genes at the cellular level. We addressed this challenge in the last funding cycle by
developing an allelic series of knock-in mice where endogenous wild-type (WT) or mutant MeCP2 was tagged
by Cre-dependent biotinylation, thus allowing the isolation of WT-expressing and mutant-expression nuclei
from the same heterozygous female brain. This strategy effectively circumvents the X-linked cellular mosaicism
in heterozygous females but also overcomes cell type heterogeneity in the brain. Using this strategy, we
completed a series of transcriptome profiling longitudinally across different stages of disease progression in a
RTT relevant heterozygous female mouse model. We found that beginning soon after the developmental
increase in non-CG DNA methylation (mCA) in early life, MeCP2-mutant neurons gradually accumulate small-
magnitude changes in gene expression over time. In contrast, neighboring wild-type neurons are not affected.
These findings raise new outstanding questions about 1) the molecular trigger that elicit more changes in gene
expression over time; 2) the changes to the abundance of mRNAs that localize to specific cellular
compartments; and 3) the origin of synaptic deficits at the level of individual synapses. We propose to address
these questions with new and innovative genetic and genomic tools, including spatial transcriptomics, in this
application. Our goal is to uncover pathogenic mechanisms of RTT and gain insights into the molecular and
cellular control of neuronal gene expression and neural development in general.

Public health relevance
Narrative Rett Syndrome is caused by mutations in the X-linked gene encoding methyl-CpG binding protein 2 (MeCP2). Despite this established genetic basis, the precise mechanisms underlying Rett Syndrome remain unclear, which hampers therapeutic advancements. This study seeks to explore these mechanisms across various molecular and cellular levels using mouse models with an objective to discover new therapeutic strategies not only for Rett Syndrome but also for related neurological disorders.